Dynamic, Cellularized, 3D Printed Model Development for Aerosol Targeting in Pediatric JORRP Patients

PROJECT ABSTRACT
Juvenile Onset Recurrent Respiratory Papillomatosis (JORRP) is a rare disease in children that causes
papillomatous legions on the glottis (voice box) leading to significant airway obstructions and difficulties with
eating, speech, and breathing. The current treatment is surgery and, to minimize surgical damage, diseased
cells are usually left behind in surgery and regrow. This leads to a vicious cycle of regrowth and repeated surgical
intervention, with some children requiring as many as 12 surgeries each year. In an analogous HPV eye infection,
ocular conjunctival papilloma legions are managed with eye drop delivery; however, there are currently no
equivalent options for direct topical therapeutic delivery to the glottis. Unfortunately, pediatric preclinical drug
delivery models are notably absent in the field, including those that might enable development of customized
pediatric inhalation therapies. There is a significant remaining challenge to develop high-throughput, integrated
preclinical models that accurately predict drug transport within the unique physiology of pediatric patients,
especially in regions of high mobility such as the glottis. The overall objective of this work is to engineer a
first-in-kind experimental pediatric “breathing pharyngeal” model, allowing us to directly establish
spatial drug deposition profiles in pediatric-specific airways under realistic breathing conditions. This
design-driven objective will require integration of pediatric imaging, automation, and tissue-mimicry, combining
discrete engineering design approaches to create critical experimentally capacity for drug transport studies under
accurate physiological movement. In Aim 1, we will develop analogous in silico and in vitro dynamic glottis
models. We will employ novel computational fluid particle dynamics (CFPD) modeling techniques capturing
glottis motion. We will vary patient geometry, air flow rates, and particle sizes, creating a library of aerosol
deposition profiles and trends. These simulations will complement and inform the in vitro model development;
we will integrate technological engineering designs with patient airway replicas utilizing motorized, flexible glottis
sections in line with a particle collection impactor to quantify particle deposition. In Aim 2, we will increase particle
delivery to the glottis by leveraging CFPD modeling to identify promising parameters with the greatest probability
of successful targeting and subsequently replicate and interrogate the simulations in vitro. We will incorporate
cellularized hydrogels into the model to ensure disease development and physiological environments are
accurately represented, varying thickness and including a complex cellular co-culture will ensure accurate
mimicry of physiological and disease development. This project will result in the generation of 1) novel dynamic
pediatric glottis computational models, 2) a preclinical tool to establish pediatric aerosol delivery, and 3) evidence
of customizable inhalable therapies to treat obstructive pediatric airway diseases.

Public health relevance
PROJECT NARRATIVE The average Juvenile Onset Recurrent Respiratory Papillomatosis (JORRP) patient is 4 years old, has a monthly surgery to remove the rare growths in the throat, will eventually develop deficiencies in speaking, breathing, and eating due to the repeated surgeries, and has an 11% chance of developing cancer. The existing topical treatments of the eye-version of JORRP (ocular papillomatosis) applied to the impacted pediatric airway could eliminate these costly, dangerous, and frequent pediatric surgeries; however, this has yet to be accomplished due to a lack of physical models capable of predicting drug response in this region of the airspace. We aim to create a physical model of JORRP obstructions by combining 3D printing of pediatric upper airways with cellularized hydrogels mimicking the microenvironment to promote development of new treatment options that these children deserve.